Chemically regulating AAV transgene expression with endogenous gene activators

Abstract
AAV gene therapy has applications for the treatment of diverse genetic diseases and has already been applied
in over 1,000 humans to date. Optimistic clinical data using AAV gene therapy has been observed for disorders
of the muscle, blood, brain, and those affecting vision. In all these applications, the AAV vectors administered
to humans have one thing in common: they are uncontrollable at the level of transgene expression. Following
transduction, AAV vector genomes form circular concatemers and limited studies have demonstrated these
episomes associate with histones as well as transcriptional activators and repressors. These observations
suggest a formal possibility that AAV episomes are, in part, restricted for transgene expression, alluding to the
ability to modulate their epigenetic composition to enhance and/or repress the transcriptional activity. We
recently developed a technology termed chemical epigenetic modifiers (CEM)s that couple a protein targeting
system at a promoter to control gene expression with a specific small molecule activator. This exciting
technology has demonstrated specific gene activation and repression at the chromosomal level. In preliminary
studies, our technology was evaluated for the recruitment of specific transcriptional and epigenetic regulators
to transduced AAV vector episomes. The resultant data demonstrate the involvement of specific epigenetic
modifiers to enhance transgene expression greater than 10-fold at a fixed vector dose. Additionally, the unique
CEM design allows binding of competitive inhibitors of the activation molecules, thereby providing a
mechanism for transcriptional repression. Excited by these findings, we propose a detailed mechanistic
examination of this platform for controlled AAV transgene expression in vitro using chromatin
immunoprecipitation following cell transduction (Aim 1). Additionally, the functionality of this CEM approach for
episomal transgene regulation will be evaluated following systemic AAV administration in a mouse model (Aim
2). Collectively, data generated herein will characterize the natural restriction on AAV transgene expression
while investigating a novel approach in vivo for the controlled and specific activation and repression of AAV
transgenes towards safer gene therapy applications in general.

Public health relevance
Project Narrative Gene therapy has the potential to be transformative in advancing human health by supplementation of corrected genetic material alleviating a broad swath of human diseases. Typical AAV therapy includes a single injection of an AAV construct to a patient with no way to regulate transgene expression following delivery. Here we advance a new technology with the ability to control AAV vectors post- administration with small regulatory chemicals. The platform technology evaluated here has the potential for treatment of many diseases using safer controlled therapeutics.